Research Training in Hematology at UNC Chapel Hill

Abstract:
The Hematology T32 Training Grant at the University of North Carolina at Chapel Hill (UNC-CH) remains
committed to training both MD physician-scientists and postdoctoral PhD scientists for careers in academic
hematology and hematology research. With 5 positions, the program will continue to train the most
promising clinical fellows, primarily from adult and pediatric hematology, as well as PhD post-doctoral
candidates in areas of traditional institutional research strength that encompass benign hematology. These
areas of focus are 1. hemostasis/thrombosis/platelet biology; 2. sickle cell disease/hemoglobinopathies; and 3.
transfusion medicine. Both basic bench and clinical research tracks are offered, with carefully selected
didactic coursework to complement the training experience. All trainees will complete instruction in scientific rigor
and reproducibility, basic biostatistics, and grants writing and scientific presentation. Additional didactic instruction will be
individualized for trainees, with bench researchers receiving formalized training in techniques and concepts that are
most relevant to their research focus. Trainees with a primary emphasis in clinical research will be expected to carry a
heavier course load unless they have previously obtained a Masters in Clinical Research or equivalent qualification.
Those without this background will be encouraged to pursue an MSCR degree in the Gillings School of Public Health.
The research mission of the recently created ‘UNC Blood Research Center’ encompasses precisely the same areas of
focus in non-malignant hematology under a new organizational structure that enhances the opportunities for training
and team science. In this competitive renewal, scientific and educational interactions between MD and PhD
trainees in the form of conferences, journal clubs, and symposia have been emphasized. Following 2 years
of training on the T32 grant, trainees will be encouraged to apply for individual or institutional K series
awards, and/or other sources of independent research funding.

Public health relevance
PROJECT NARRATIVE This is a competitive renewal application for years 46-50 of a T32 program to train postdoctoral investigators in basic and translational benign hematology research. Our program’s primary goal is to develop future academic and scientific leaders in benign hematology research by training promising MD, PhD (or other similar degree) postdoctoral scientists to become independent laboratory-based and translational investigators focused on clinically relevant non-malignant hematology research topics. Highly qualified applicants will undergo comprehensive interdisciplinary research training and career development that prepares them well for sustained, impactful independent research careers.